Investigating the Impact of Novel Senescent Microglia in Alzheimer's Disease Progression

Title: Inves�ga�ng the Impact of Novel Senescent Microglia in Alzheimer's Disease Pathology
Abstract: Alzheimer's Disease (AD) is a debilita�ng neurodegenera�ve disorder with a cri�cal need for
improved therapeu�c strategies. One controversial component of AD progression is the role of microglia,
the brain's immune cells. Recent research indicates a subpopula�on of these cells exhibi�ng senescence
characteris�cs, raising the ques�on if these senescent microglia might contribute to AD progression
through a senescence-associated secretory phenotype (SASP). Our proposal aims to elucidate the role of
these cells in AD using a two-fold approach: deﬁning and characterizing these senescent microglia through
proteomic, transcriptomic, and spa�al-omics proﬁling (Aim 1) and inves�ga�ng whether removing these
senescent microglia can slow or delay AD progression (Aim 2). We plan to leverage a novel transgenic
mouse model to selec�vely ablate newly iden�ﬁed senescent microglia and assess the subsequent impact
on AD progression. If successful, these studies could oﬀer novel insight into AD pathology and iden�fy
poten�al therapeu�c targets by focusing on the selec�ve elimina�on of senescent microglia.

Public health relevance
Lay summary: Alzheimer's Disease, a serious brain disorder, needs better treatment methods. This project is about studying a special group of brain's immune cells that may become old and not work properly, which could make Alzheimer's worse. We aim to learn more about these cells and see if getting rid of them can help slow down Alzheimer's. We'll use a special kind of lab mouse to help with this. If this works, we could learn how Alzheimer's develops and potentially find new ways to treat it by focusing on these old cells.